Administrative Core

PROJECT SUMMARY: ADMINISTRATIVE CORE
NIDDK-funded training programs have been essential for fostering the career development of scientists and
physician-scientists tackling questions in the kidney, urology and hematology (KUH) research areas, but these
programs have yielded varying degrees of success. To best meet future challenges, NIDDK understands the
need to train promising individuals for interdisciplinary team science and draw upon extensive, collaborative
resources to establish communities of trainees. Chicagoland is a metro area rich in world-class medical centers
and other resources essential to establish such an interdisciplinary training program and make sustained impacts
on KUH research training. The interdisciplinary Chicago Kidney Urology Hematology network FOR city-Wide
reseArch tRaining and career Development (Chicago KUH FORWARD) brings together 6 public and private
academic institutions that provide unique and complementary training opportunities across Chicagoland. These
critical assets must be coordinated to yield the best training opportunities for fellows and to maximize
effectiveness of the Professional Development, Network and Training Cores. The Administrative Core will
ensure effective function of Chicago KUH FORWARD through establishing shared governance, collaborative
workflow, continual assessment and improvement, and disseminating the work and successes of trainees
through yearly NIDDK U2C/TL1 KUH Institutional Network meetings. The Specific Aims of the Administrative
Core are: 1) Establish an organizational and governance structure fostering communication, collaboration and
integration; 2) Develop comprehensive program evaluation, data review and cycles of improvement; 3) Establish
an External Evaluation Board (EEB) for performance and diversity oversight; and 4) Organize a meeting of the
NIDDK U2C/TL1 KUH Institutional Network. The Administrative Core will be directed by Dr. Alfred George, who
has extensive experience in the oversight of training programs, shared leadership of the George M. O'Brien
Kidney Research Core Center at Northwestern University (NU-GoKIDNEY) and leadership of large collaborative
research projects, which have necessitated oversight and management of multiple subcontracts. Dr. Pinelopi
Kapitsinou will serve as the Co-Director and she has experience in co-leading a NU-GoKIDNEY Research Core.
They will be assisted by dedicated Program Coordinator and Manager, who will serve all aspects of the program
and will facilitate effective communication and integration of Cores and Committees. Experts in education and
evaluation will lend their expertise to ensure continual cycles of evaluation and improvement. An inter-
institutional Steering Committee with shared leadership and representation of all stakeholders will foster equitable
governance among disciplines and institutions. Together, successful completion of these Aims and effective
function of the Administrative Core will result in an interdisciplinary and collaborative environment that draws
upon the unique and complementary strengths of our world-class research institutions to train the next generation
of KUH researchers. This training environment will contribute to an important nationwide Institutional Network.